CRCNS: Multimodal integration for spatial navigation

Spatial orientation is a fundamental cognitive function required for survival. To navigate, an animal must
know its location and its heading. The neurons thought to underlie the sense of direction are known as
head-direction cells, which respond maximally when an animal is facing in a particular direction.
Collectively, these cells form a cognitive map, analogous to a compass, that specifies heading direction
relative to the surrounding world. How do neural circuits evaluate and combine multimodal cues to
robustly and accurately build a cognitive map? This proposal applies an integrated experimental and
theoretical approach to a well-characterized navigation center, the Drosophila central complex and, in
particular, the ellipsoid body, which is known to use multimodal sensory information to provide the fly with
its sense of orientation in the world. One of the most important cues that flies and other insects use for
this purpose is the sky. In addition to the location of the sun, insects use the polarization pattern and
chromatic gradient of sunlight scattered by the atmosphere, which persist even when the sun is clouded
over. Lightpolarization has a preeminent role in controlling the fly's compass system, but polarization, by
itself, suffers from a 180° ambiguity as a directional signal. We hypothesize that the compass system
resolves this ambiguity by combining polarization and sky-color information, and that these together are
the primary drivers of the heading direction system in a natural setting. Our preliminary data supports this
hypothesis by showing that a visual ring neuron, presynaptic to directional-selective compass neurons,
integrates polarization and color information. The proposed work will unravel fundamental mechanisms of
sensory integration for goal-directed behavior by 1) Determining how chromatic information is relayed to
the Drosophila compass system, 2) Uncovering how ch romatic signals are combined with polarization
signals to create an unambiguous sky map, and 3) Exploring the dominant role played by sky compass
signals and how they interact with other directional cues to determine heading direction.
RELEVANCE (See instructions):
The completion of the proposed aims will explain how neural circuits construct a cognitive map by
optimally weighing multi-sensory streams to achieve a robust yet flexible representation of direction in the
world. The achieved understanding will be mechanistic, at the level of specific neurons and synapses. Our
focus on multisensory integration will have broad implications for many cognitive functions, such as
learning and memory, which require integrating multimodal cues.